Administrative Core

PROJECT SUMMARY/ABSTRACT
Despite the increasing national distribution and dissemination of COVID-19 vaccines, uptake and completion of
COVID-19 vaccine remains low among minorities. Underresourced groups, specifically minorities, are
experiencing exponentially high morbidity and mortality rates, in addition to poorer health outcomes, during the
COVID-19 pandemic. This is compounded by higher levels of vaccine hesitancy within this population, which
may be attributed to a myriad of issues, including medical mistrust and lack of access to health services. One
particular group, African American and Latinx public housing residents, are facing adverse effects related to
worsening social determinants and health disparities. Utilizing a community-driven approach, the overall
objective of this proposed study is to increase COVID-19 vaccine uptake and completion among African
American and Latinx public housing residents. Guided by the Community Based Participatory Model, the
Information, Motivation, and Behavioral Skills (IMB) and the Transtheoretical Model will be utilized to carry out
this intervention. Through this innovative program, we will establish the Academic-Community Team for
Improving Vaccine Acceptability and Targeted Engagement (ACTIVATE) program, which will develop
leadership triads of public housing resident leaders, nurse practitioner students, and public health students to
carry out this multilevel intervention. The multidisciplinary, theoretically-based, culturally-driven proposed
project is evidence-informed and promising for African American and Latinx public housing residents and will
be advanced through the following three aims: 1) To conduct a 12-week training of 30 ACTIVATE triads, who
will master information about COVID-19, and increase in knowledge and skills to address the social,
behavioral, and healthcare-related vaccination challenges among African American and Latinx public housing
residents. 2) Through the engagement and empowerment of 30 ACTIVATE triads, to jointly implement a
community-driven, culturally-sensitive plan that will a) reduce mistrust, fatalistic beliefs, and psychosocial
barriers to COVID-19 vaccine acceptance and b) increase receptivity and willingness for uptake of COVID-19
vaccine among 600 residents in public housing areas. And 3) using a pretest-posttest design, to investigate the
impact of a longitudinal, ACTIVATE-led intervention on the completion of the COVID-19 vaccine series among
252 African American and Latinx public housing residents reporting vaccine hesitancy following the Aim 2
community-level intervention. The outcomes of this proposal will produce community- and health-professional-
based vaccine leaders that can increase COVID-19 vaccine acceptance among minority public housing
residents, inducing sustainability. Overall, this study will influence evidence-based practice and inform
healthcare professionals, community groups, and policymakers on improving access and culturally-sensitive
resources for COVID-19 vaccination for these underserved populations during and after the pandemic.

Public health relevance
PROJECT NARRATIVE This proposal seeks to decrease vaccine hesitancy and improve acceptance of COVID-19 vaccination among African American and Latinx public housing residents in South Los Angeles. Given the multiple COVID-19 disparities experienced by this population, we will implement a multilevel, multidisciplinary, and community- driven intervention to engage this population in the uptake of the COVID-19 vaccination.